The Mast cell - IL-33 Axis in Post-traumatic Osteoarthritis

Investigators: Abigail Loucks, MS (PhD Student), Aimee Colbath, VMD, PhD, DACVS-LA (Sponsor), Tristan
Maerz, PhD (Co-Sponsor). Contributors: Adam Moeser, MS, PhD, DVM; Dana Orange, MD, M.Sc.
Context: With identification of synovitis as a driver of osteoarthritis (OA), recent studies have placed an
increasing focus on the synovium and the role of intra-articular inflammation in OA pathogenesis. Mast cells
(MCs) are long-lived tissue-resident immune cells that act as early responders to infection or injury. Here we
are looking to evaluate the temporal role of MCs in post-traumatic osteoarthritis (PTOA) progression and a
potential mechanism via IL-33 signaling to alter MC phenotype to mitigate disease severity following an injury.
In PTOA patients, OA may be initiated by an isolated event; therefore, a window may exist for therapeutic
intervention by immune modulation before the disease progresses. Therefore, the overall objective of this
proposal is to further elucidate the phenotype and functions of MCs in the acute and chronic phases of PTOA.
Our central hypothesis is that MCs are pro-inflammatory in the acute phase following injury, but prolonged
stimulation of MCs by IL-33 results in an immunomodulatory phenotype, mitigating joint inflammation.
Specific Aims: To test our hypothesis and achieve our long-term goal to enhance endogenous
immunomodulatory activity of MCs following joint injury through manipulation of IL-33 signaling we aim to (i)
identify the temporal role of MCs in PTOA and (ii) determine the role of IL-33 in mediating MC phenotypes
during disease progression.
Research Plan: Aim 1) The effect of MCs on PTOA progression during the acute and chronic phase of the
disease will be evaluated by ablating MCs in an MCPT5-Cre x iDTR mouse model 24hrs prior or 10 days after
mice undergo a non-invasive anterior cruciate ligament rupture (ACLR). Histology grading of hind limbs will be
used to evaluate PTOA severity and single cell RNA sequencing to unbiasedly assess transcriptional changes
surrounding MCs in PTOA. Aim 2) We will assess the long- and short-term effect of IL-33 on MC phenotype in
both murine bone marrow derived mast cells (mBMMCs) and a human mast cell line (LADR) by culturing cells
with recombinant IL-33 for either 24hrs or 7 days followed by stimulation with both IgG and IgE or IgE,
respectively. Expression of a known activation marker, CD63, and expression of well-known MC-associated
genes will be analyzed via flow cytometry and RT-qPCR, respectively. Media will be analyzed for cytokine and
chemokine release via multiplex assay. An IL-33 conditional knockout (Pdgfra-CreER; IL33 f/f) will be utilized
to study the progression of PTOA with or without IL-33 released by synovial fibroblasts (SFs) 24hrs prior or 10
days after mice undergo (ACLR) procedure based on histology grading of PTOA severity. Bulk RNA-seq of
flow sorted MCs from synovium of these mice will identify alterations in biological processes related to immune
cell recruitment and synovitis as associated with MCs present within the joint.

Public health relevance
Project Narrative It is now well recognized that the interaction between local tissue damage and the innate immune response drives the progression of PTOA; however, the understanding of the inflammatory pathways contributing to disease severity remains incomplete. Mast cells with their stored granules can respond quickly and potently to disease, affecting joint and immune cell populations with their powerful immunomodulatory abilities. This proposal involves a diverse training program encompassing in vitro and in vivo models relevant to mast cell biology and musculoskeletal transcriptomics to evaluate the role of the mast cell – IL33 axis in regulating PTOA progression and identifying a temporal role for MCs in PTOA.